VIRTUAL RESEARCH SUPPORT PILOT

The Division of Cancer Treatment and Diagnosis, NCI is requesting support for establishment of a Virtual Research Support Pilot to Enhance minority and underserved population accrual to NCI clinical trials